MassHEAL - Reducing overdose deaths by 40% (2019-2023)

Project Summary/Abstract
This supplement aims to explore the impact of the infusion of health equity principles on overdose prevention
strategies during implementation of the Communities That Heal (CTH) intervention as part of the HEALing
Communities Study (HCS). The HCS is a multi-site, parallel arm, cluster randomized, wait-list controlled trial
evaluating the impact of the CTH intervention compared with usual care in wait-list communities, on overdose
deaths. The overall goal of the HCS is to reduce opioid overdose deaths by 40% in 67 HCS communities
across four states. Communities form coalitions to make shared decisions about what overdose prevention
strategies to implement and how best to implement them, particularly strategies that promote Overdose
Prevention Education and Naloxone Distribution (OEND) and Medications for Opioid Use Disorder (MOUD).
While it is known that minoritized communities (whether due to race, ethnicity, gender, or LGBTQIA+ status)
have less and poorer access to treatment for Opioid Use Disorder (OUD) and associated disparities in
outcomes, at its outset, HCS did not explicitly aim to reduce disparities or measure the effect of centering
equity on overdose prevention. This approach changed in 2020 with acute awareness of the racial and ethnic
disparities within the COVID epidemic and the racial awakening in response to the George Floyd killing. This
supplement will leverage the existing infrastructure and study stuff of its parent study to analyze survey and
other qualitative data already collected. The primary data sources will include surveys of coalition members,
completed at four time points during the study period; the Opioid-Overdose Reduction Continuum of Care
Approach Tracker (ORCCAT), completed monthly by study staff, that includes overdose prevention information
by strategy, sector, venue, population served, coalition approval date, implementation plan developed, date
started, number of partners/practices associated with strategy, and mode of delivery; and REACH data,
completed by study staff monthly once each strategy is implemented that includes information on number of
persons reached and demographics of those reached (e.g., race, ethnicity, sex, age). Data analysis will include
both quantitative analysis looking at associations between survey answers regarding health equity topics and
incorporation of equity into strategies, as well as qualitative analysis examining how coalitions discussed and
prioritized equity topics. This study will be guided by the parent study’s PRISM/RE-AIM(S) conceptual
framework with a novel health equity lens to examine how diversifying coalitions and infusing opioid overdose
prevention strategies with health equity principles may help reach minoritized communities and how these
contextual factors and processes may interact to promote or impede health equity. Results from this study may
be used to inform policies, strategies, and practices for incorporating health equity principles when
implementing overdose prevention strategies.

Public health relevance
Project Narrative This supplement aims to explore the impact of the infusion of health equity principles on overdose prevention strategies during implementation of the Communities That Heal (CTH) intervention as part of the HEALing Communities Study (HCS). We will analyze existing survey data of community coalition members, process data describing successfully implemented overdose prevention strategies, and coalition meeting minutes that provide important context for decision-making around health equity principles. This study will be guided by the parent study’s PRISM/RE-AIM(S) conceptual framework with a novel health equity lens to examine what contextual factors and processes promoted or impeded incorporation of health equity principles into overdose prevention strategy implementation.